A Different Type of Economic Fragility: Wealth and Adolescent Problem Behavior

Project Summary
The proposal addresses the ongoing mental health crisis among adolescents by considering the overlooked role of wealth
and wealth deprivation in driving adolescent problem behaviors. The literature on economic disadvantage and behavioral
health has taken a myopic view of the economic circumstances that drive problem behaviors, focusing nearly exclusively
on income, while ignoring wealth (household assets minus debts). Wealth is distributed more unequally than is income with
roughly one-third of child households experience wealth deprivation. This study will be the first longitudinal study of a
diverse cohort of families that observes wealth, income, and adolescent development. With a socioeconomically and racially
diverse sample of youth (ages 13-15 years; N = 750) and their caregivers, this investigation has three aims. First it will
repeatedly measure (9 observations nested within individuals) family wealth from comprehensive sources and gain a more
accurate understanding of wealth inequality and net worth poverty over time across different SES, racial, and ethnic groups.
Second, it will probe how wealth interfaces with family income and income volatility and how these factors relate to problem
behaviors. Considering that the recent growth in wealth disparities has far outpaced income disparities, we believe it critical
to consider how wealth levels and deprivation relate to youth problem behaviors. Third, it will test multiple pathways
through which wealth may relate to adolescent problem behaviors. These include: 1) investments of time and money, 2)
caregiver and adolescent stress, 3) caregiver and adolescent expectations for the future, and 4) perceptions and
manifestations of social class. Examined collectively, the proposal contributes new knowledge and connects to NICHD
priorities by providing rich descriptive information as to how adolescents’ problem behaviors are shaped by family wealth
and how such experiences interface with other dimensions of family economic circumstances to contribute to adolescent
development. The project’s robust analysis of four developmental pathways will be crucial for informing prevention and
intervention efforts aimed at reducing problem behaviors and promoting children’s psychosocial functioning among
adolescents in families experiencing wealth deprivation.

Public health relevance
Project Narrative The proposed study considers how wealth and wealth deprivation contribute to youth problem behaviors. It will comprehensively test four psychosocial pathways as potential mediators linking wealth to problem behaviors, as well as provide descriptive data about variations in wealth over time within a socioeconomically and racially/ethnically diverse group of families with adolescents. Such information will be critical for the development of prevention and intervention efforts aimed at promoting adolescents' psychosocial functioning in economically marginalized families.